Beckman Coulter Biomek i7 Hybrid automated workstation

PROJECT SUMMARY
Sanford Burnham Prebys Medical Discovery Institute (SBP) has 40 research labs specializing in cancer,
children’s health, stem cells, degenerative diseases of aging, as well as infectious and other diseases. Many
recent advances in medical research and healthcare rely on the discovery of novel therapeutic targets. Recently,
advances in functional genomic technologies have provided an unprecedented opportunity to understand
fundamental mechanisms underlying diseases initiation, progression, and relapse. Thus, these technologies
hold great promise in the identification of novel targets and innovative treatments.
In order to remain cutting-edge, the SBP Functional Genomics Core Facility seeks funding to acquire the
Beckman Coulter Biomek i7 Hybrid automated workstation. This fully automated system, with 8 independent
pipettes and interchangeable 96 and 384-multichannel liquid handling platforms, will replace our existing
outdated, underperforming Hamilton Microlab STAR (2005 model year, 96-well platform) and Agilent Bravo
(2010 model year, 384-well platform) equipment. Even after expensive software and hardware upgrades, both
the Hamilton STAR and Agilent Bravo models will still fall short of automating the desired library preparation and
screening workflows demanded by the NIH-funded projects that are currently being supported by our core facility.
A key part of this enhancement is the production and screening of large-scale arrayed CRISPR libraries, which
enables a wide variety of new scientific approaches not possible with pooled or small-scale arrayed CRISPR
library analysis. In contrast to the Hamilton STAR and Agilent Bravo, the new Biomek i7 enables streamlined
automation of multiple continuous pipelines and mitigates capacity limitations. Designated pipelines include high-
throughput production of bacteria, viral vector plasmids, recombinant viruses, and mammalian cell cultures, as
well as cell-based phenotypic screening and assay processing, which can be accomplished on a 96/384-well
platform.
This application is supported by eight major SBP users with active NIH-funded projects. As stated in the
application, the projects of all eight major users - together accounting for 77% of the Biomek i7’s available use
time (AUT) - will greatly benefit from the Biomek i7 automation to advance their proposed studies in diverse
human disease research topics including cancer, aging, muscular dystrophy, Alzheimer’s disease and related
dementia, and COVID-19.

Public health relevance
PROJECT NARRATIVE The SBP Functional Genomics Shared Resource conducts various high-throughput chemical and genetic screens using the Hamilton STAR and Agilent Bravo equipment, which have reached their hardware capacity and limits and are therefore obsolete. Users at the shared resource are unable to operate these semi-automated platforms to execute high-valued arrayed library screening and resolve critical questions raised in current NIH- funded research. Fortunately, the proposed high-throughput automation model, Beckman Coulter Biomek i7, will be able to streamline the entire screening process, including assay development, arrayed library preparation and screening, and target validation in cellular disease models. The acquisition of the Beckman Coulter Biomek i7 will help propel the discovery of novel targets and their underlying mechanisms, advancing our understanding of a wide spectrum of human diseases. The disease indications being studied at SBP that will benefit from this automation include COVID-19, childhood diseases, including leukemia, brain cancer, and Duchenne Muscular Dystrophy, as well as adult diseases such as breast cancer, aging-specific chronic inflammation, Alzheimer’s disease, and its related dementia. Deployment of the Biomek i7 automation will help accelerate the development of innovative therapeutics, which is the primary objective of these NIH-funded projects.